SKELETAL CHANGES IN VERY LOW BIRTH WEIGHT INFANTS

Systematic study to evaluate (1) the etiologic factors, (2) the clinical signs and causes and (3) the natural history with respect to healing of rickets/fractures in very low birth weight infants.